Deciphering the molecular landscape of frontotemporal lobar degeneration: A network-based proteomic approach

PROJECT SUMMARY/ABSTRACT
This K23 career development award aims to support Dr. Rowan Saloner in acquiring the expertise to become a
leading clinical researcher focused on unraveling the neurobiological underpinnings of clinical progression in
frontotemporal lobar degeneration (FTLD), Alzheimer's disease (AD), and other related dementias (ADRD), Dr.
Saloner is a clinical neuropsychology postdoctoral fellow transitioning to faculty at the University of California,
San Francisco, Memory and Aging Center (MAC), This K23 will focus on large-scale proteomics, clinical
characterization, and bioinformatics to identify fluid biomarker signatures of FTLD and their relationship to
disease progression. Through the enriched multidisciplinary training environment at the MAC, Dr. Saloner aims
to accomplish the following training goals: 1) clinical integration of deep molecular phenotyping of ADRD; 2) big
data/bioinformatics; and 3) scientific leadership, Dr. Saloner will translate his K23 experience into future R01
efforts to integrate high-dimensional biological tools with detailed clinical phenotyping to refine personalized
biomarkers for diagnosis, prognosis, and therapeutic target engagement in ADRD. Dr. Saloner has assembled
an exemplary mentorship team with expertise in neurobehavioral aging (Primary Mentor Dr, Kaitlin Casaletto ),
ADRD fluid biomarkers (Co-Primary Mentor Dr. Adam Boxer), proteomics (Co-Mentor Dr, Nicholas Seyfried),
biostatistics (Co-Mentor Dr. John Karnak), disease progression modeling (Collaborator Dr. Adam Staffaroni),
FTLD biology (Advisor Dr. Jennifer Yokoyama), and professional development (Advisor Dr. Joel Kramer).
The central rationale is that the most potent therapeutics for ADRD will modify molecular targets that change
early in disease and have downstream effects on neuron loss and cognitive decline. Cutting-edge proteomic
platforms that measure thousands of proteins in a single biospecimen sample have advanced understanding of
AD biology in living humans. However, far less is known regarding the molecular evolution of FTLD, a common
cause of young-onset dementia for which there are no effective therapies. The proposed study will leverage
large-scale proteomics in cerebrospinal fluid (CSF) and plasma to identify protein signatures that precede and
predict brain atrophy and cognitive decline in carriers of autosomal dominant FTLD mutations, who represent an
ideal population to study early ADRD biomarkers. Antemortem CSF and plasma proteomic data in sporadic,
pathology-confirmed FTLD will also be leveraged to determine the degree to which genetically-derived protein
signatures translate to sporadic FTLD, which represents the majority of FTLD cases. Examining deep molecular
screening tools in relation to FTLD progression strongly aligns with Actions 1.B.1 ("Expand research to identify
the molecular and cellular mechanisms underlying Alzheimer's disease and related dementias") and 1.C, 1
("Identify imaging and biomarkers to monitor disease progression") of the 2022 National Plan to Address
Alzheimer's Disease. Successful completion of study aims will advance discovery of early FTLD biology in
humans and identify targets for the development of urgently needed FTLD biomarkers and treatments.

Public health relevance
PROJECT NARRATIVE The most powerful treatments for neurodegenerative disease will target molecular pathways that are affected early in the disease course, prior to irreversible brain atrophy and cognitive impairment. The proposed project will leverage large-scale proteomics to discover blood and cerebrospinal fluid protein changes that precede and predict the earliest clinical manifestations of frontotemporal lobar degeneration (FTLD), a common cause of young-onset dementia for which there are no effective therapies. This project will advance fundamental understanding of the biological pathways that are affected early in FTLD and identify high-priority targets for FTLD biomarker and therapeutic development.